Biomarkers of Sulforaphane/Broccoli Sprout Extract in Prostate Cancer

Abstract Malignancy of the prostate remains a leading cause of cancer-related deaths among American men. Chemoprevention using safe and inexpensive phytochemicals from edible or medicinal plants is clinically attractive for reducing both morbidity and mortality from prostate cancer. Sulforaphane (SFN), which is the principal bioactive phytochemical in broccoli sprout extract (BSE), has emerged as a particularly potent chemopreventive agent based on its ability to target multiple mechanisms to control carcinogenesis. The overall goal of the parent NCI-funded R01 award (R01 CA225716-02) was to determine the feasibility of inhibiting fatty acid metabolism for chemoprevention of prostate cancer using SFN and BSE. This revision application will incorporate the IMAT-funded super-resolution microscopy technology that can detect the cumulative changes in disrupted nanoscale chromatin folding at different epigenetic states during carcinogenesis to (a) accurately quantify the reduction of cancer risk from multiple molecular pathways and (b) further understand the alteration of higher-order chromatin folding under the influences of metabolism in the context of chemopreventive intervention for prostate cancer. This revision project will incorporate the IMAT-funded super-resolution microscopy as follows: Specific Aim 1: Determine whether chemoprevention of prostate cancer by SFN and BroccoMax® (which is being used as a source of SFN in the clinical trial in specific aim 3 of the parent R01) in Hi-Myc transgenic mice is associated with alterations in nanoscale chromatin folding. Specific Aim 2: Determine whether higher-order chromatin folding is altered in PTEN-deletion mouse model of prostate cancer, and whether this phenotype is reversed following dietary administration of SFN and BroccoMax®. Specific Aim 3: Validate the human relevance of disrupted chromatin folding and evaluate its feasibility to risk-stratify patients with prostate cancer. Impact: This revision project will open a new avenue for cancer risk stratification and facilitate the evaluation of chemopreventive intervention and establish the relationship between disrupted nanoscale chromatin folding that fuels carcinogenesis and metabolism in the context of chemopreventive intervention.

Public health relevance
PROJECT NARRATIVE The overall goal of the parent R01 project (CA225716-02) is to determine the feasibility of prostate cancer prevention by sulforaphane (SFN), which is the principal bioactive phytochemical in broccoli sprout extract (BSE). The preclinical studies are conceived to test the hypothesis that prostate cancer chemoprevention by SFN and BSE in a clinically-relevant transgenic mouse model (Hi-Myc) is associated with suppression of synthesis and/or β-oxidation of fatty acids leading to inhibition of prostate cancer cell proliferation. A pilot double-blind, randomized, and placebo-controlled window of opportunity trial in men scheduled for prostatectomy is also designed to determine whether daily oral administration of a well-characterized BSE formulation (BroccoMax®) for 4 weeks leads to suppression of circulating (serum) and prostate tumor levels of fatty acids. This revision project will utilize prostate tissues from the specific aim 2 of the parent R01, tissues from PTEN-KO mice (specific aim 2 of the revision application), and human specimens (specific aim 3 of the revision application) to determine whether nano-scale changes in chromatin folding can serve as biomarkers of prostate cancer prevention by SFN. Specific aim 3 of this revision application may also help stratify prostate cancer severity together with Gleason score to avoid over diagnosis and/or over treatment.